ACTIVITY OF 3'THEACYTINIDINE IN HIV POSITIVE PATIENTS WITH ADVANCED ARC OR AIDS

This is a Phase I/II study designed to evaluate the safety, pharmacokinetics and preliminary activity of 2'-deoxy-3'-thiacytidine (3TC) in patients with the acquired immune deficiency syndrome (AIDS) or AIDS-related complex (ARC). This open-label, multi-center, noncomparative, dose-escalating study will enroll 10-15 patients at each dose level.